Equipment Supplement: Increasing the Selectivity of Hybrid Mass Spectrometry using Multidimensional Ion Mobility Spectrometry

Project Summary/Abstract The requested supplement is to purchase an autoclave. Specific details on the requested equipment can be found in the Budget Justification. The

Public health relevance
PROJECT NARRATIVE The requested supplement is to purchase an autoclave. Autoclaving is critical to this project because each aim uses recombinant proteins. This will be the only autoclave in the building that houses the PI's lab; acquisition of this autoclave will ensure continued research progress for this project and will also benefit other researchers with labs in the building.